Stimulus Control Refinements of Functional Communication Training in ID

Project Summary
Severe destructive behavior represents a comorbid condition of developmental disability for which risk
increases with intellectual disability severity, communication deficits, and co-occurring autism spectrum
disorder.24,78 Destructive behavior, such as self-injurious behavior and aggression, causes harm to the child
and others and increases the risk for institutionalization, social isolation, physical restraint, medication over-
use, service denial, and abuse.79 Clinicians have used functional analyses to identify the variables that
reinforce or motivate destructive behavior and to develop effective, function-based treatments.4 Functional
communication training (FCT) is an empirically supported, function-based treatment that decreases destructive
behavior. The clinician teaches the child to use the functional communication response (FCR) to request the
reinforcer for destructive behavior, and destructive behavior is on extinction during FCT.6,39 For example, if
functional-analysis results showed that attention reinforced destructive behavior, the clinician would provide
attention when the child used the FCR (“Play with me, please.”) and would not provide attention for destructive
behavior. One limitation of FCT is that relapse, an increase in destructive behavior after initially effective
treatment, often occurs when we transfer treatment to new therapists, caregivers, or settings or when change
agents implement it incorrectly.8,39,80,81 Behavior analysts describe relapse as (a)
renewal when the treatment
context changes (e.g., transfer treatment from clinic to home),12 (b) resurgence when the FCR does not
produce reinforcement,82 and superresurgence when renewal and resurgence co-occur and cause higher
levels of relapse than that produced by either alone,14 and (c) reinstatement when the caregiver mistakenly
provides reinforcement
at unplanned times.83 Our research from Period 1 of this project, based on behavioral
momentum theory, suggested that signaling when the FCR will and will not produce reinforcement during our
multiple-schedule FCT (mult FCT) procedure: (a) prevented extinction bursts, (b) facilitated reinforcement-
schedule thinning, and (c) prevented or mitigated relapse when caregivers did not deliver planned
reinforcement for the FCR.9 In addition, our related preliminary research showed that mult FCT often:
(a) rapidly reduced destructive behavior, (b) facilitated treatment transfer across contexts without
evoking renewal, and (c) reduced the need for a punishment component. We will conduct a randomized clinical
trial to compare the effectiveness of mult FCT to traditional FCT, which does not signal reinforcement
availability and unavailability, for mitigating renewal, superresurgence, and reinstatement. We also will test
whether mult FCT + stimulus fading, in which we conduct each context change in gradual steps, will further
reduce treatment relapse. This novel project has the potential to change the way researchers and clinicians
analyze and prevent treatment relapse, thereby markedly improving the long-term outcomes for children and
families afflicted by these debilitating behavior disorders.

Public health relevance
Project Narrative This project aims to improve treatment and to prevent relapse for severe destructive behavior exhibited by children with developmental disabilities.24,25,78 Relapse, the increase in destructive behavior after initially effective treatment, is a common problem that negatively impacts long-term treatment effectiveness and often occurs when: (a) we transfer treatment to different therapists, caregivers, or settings;19 (b) caregivers stop delivering reinforcement for appropriate, alternative behavior;9 and (c) caregivers deliver reinforcement at unplanned times.15 Our novel treatment will be more effective and will mitigate or prevent relapse more often than traditional treatments.